Resident Memory T Cells

Project Summary
The goal of this proposal is to make significant advancements in our understanding of resident memory T cell
(TRM) biology that will inform mechanisms of immunity and vaccination. TRM longevity and stability will be
rigorously examined. Moreover, the proposal will test the hypothesis that TRM exhibit developmental plasticity
and retrograde migration, giving rise to cells contained within circulating T cell populations that are significantly
advantaged to reconstitute TRM-based immunity specifically at their previous site of residence. Lastly, the
ontogeny and function of lymph node TRM will be defined.

Public health relevance
Project Narrative This proposal will make significant advances in our understanding of resident memory T cell (TRM) biology, including 1) TRM longevity and stability, 2) TRM developmental plasticity, and 3) ontogeny and function of lymph node TRM. Knowledge obtained from this proposal will inform methods of immunity and vaccination.